Chemical Genetic Analysis of RAS Signaling

Abstract
The GTPase RAS functions as a molecular “on/off” switch, existing both in GDP-bound (inactive) and GTP-
bound forms (active). Despite functioning as a simple binary switch, RAS is capable of directing complex and
diverse cellular processes, including proliferation, migration, survival, and T-cell development. Recent work
suggests that the ability of RAS to play complex, often conflicting roles in diverse processes results from
differences in cellular context and and/or subcellular localization of its signaling. We have developed a novel
chemical genetic tool–called Chemically-Inducible Activator of RAS (CIAR)–to study the dynamics of the
signaling networks that are mediated by RAS activity. CIAR allows rapid and dose-dependent activation of
RAS signaling with a cell permeable small molecule. With CIAR, we propose to use targeted, quantitative
phosphoproteomics and transcriptomics to study the fundamental dynamic behavior of RAS-driven signaling.
Subcellularly-localized versions of CIAR will also be used to determine the effects of localized RAS activation
on the dynamics of RAS-mediated signaling. Finally, we will explore positive and negative feedback within
RAS-driven signaling pathways by selectively enhancing or inhibiting downstream signaling components.

Public health relevance
Narrative RAS is a central component of many intracellular signaling networks in eukaryotes. Despite the role of mis- regulated RAS in numerous cancers, many fundamental aspects of RAS-mediated signaling are still poorly understood. Here, we will quantitatively characterize the dynamics of RAS-driven signaling in different cellular environments and explore the effects of signaling crosstalk.